UCI P30 Skin Center Imaging-Engineering Core

PROJECT SUMMARY/ABSTRACT
The Imaging and Engineering Core includes the following components: 1) Imaging platforms that harness UCI's
proficiency in multiphoton microscopy, fluorescence dynamics, and diffuse optical imaging. These platforms
enable data acquisition across various scales, from laboratory experiments to animal models and clinical
environments. 2) Tissue engineering and labeling approaches that, in conjunction with tissue clearing and
advanced imaging techniques, facilitate the exploration of genotype-phenotype relationships in the epidermis.
In the last four years, Core investigators have employed state-of-the-art technologies, including Multiphoton
Microscopy, Fluorescence Lifetime Imaging Microscopy, Coherent Raman Scattering, Spatial Frequency
Domain Imaging (SFDI), and Laser Speckle Imaging (LSI), to obtain groundbreaking findings in skin homeostasis
and disease. This research has yielded 28 peer-reviewed papers utilizing core services and 13 papers
contributing to the advancement of skin imaging technologies. Over this same timeframe, UCI Skin investigators
have expressed a need for advanced spatial phenotyping methods capable of visualizing molecular contrast at
cellular/subcellular resolution in vitro, in vivo, and in human skin at the bedside. In response to this need, we
develop advanced imaging methods capable of visualizing molecular contrast at subcellular resolution. To
explore how genotype impacts the spatial distribution of molecular contrast in tissue, we engineer tissue models
to examine genotype-phenotype relationships relevant to skin disease. The Imaging and Engineering Core has
a crucial role in offering resources for training, dissemination, and collaboration that foster and bolster
interdisciplinary efforts. Our aim is to unite technology developers, modeling experts, biologists, and clinicians
from UCI and the broader skin research community, forming teams that can exchange knowledge and utilize
new tools to address persistent challenges. This will be achieved through hands-on and didactic training, as well
as dissemination activities designed to equip skin biology researchers with advanced imaging tools for their
research.